2022 Bioinspired Materials Gordon Research Conference and Gordon Research Seminar

Project Summary/Abstract
The emerging, interdisciplinary field of Bioinspired Materials focuses on developing a fundamental
understanding of the synthesis, directed self-assembly and hierarchical organization of naturally occurring
materials, and uses this understanding to engineer new bioinspired materials for diverse applications ranging
from the delivery of therapeutics, to the assembly of organoids, to the development of artificial membranes and
synthetic cells (protocells). Many of these areas are of significant interest to NIBIB. The Gordon Research
Conference on Bioinspired Materials will take place June 5-10, 2022 at Les Diablerets Conference Center, Les
Diablerets, Switzerland, and seeks to capture the excitement of this burgeoning field with a cutting-edge
scientific program and roster of distinguished invited speakers and discussion leaders, in the unique format of
a Gordon Conference that guarantees an intimate cross-fertilization of ideas. The conference is intended to
focus on unpublished data, define new directions in the discipline, and create a cohesive community by
promoting interactions between early stage investigators and senior, established investigators. A significant
portion of the program of 2022 GRC on Bioinspired Materials meeting is the development of novel materials
that focus on applications to human health, and 1/3 of the confirmed speakers are women. All requested
support will be for travel and registration of early stage investigators; typically 67% of attendees at this highly
successful conference are in this category. The aims of the conference are to: 1) Create a scientific program
that focuses on fundamental research in Bioinspired Materials and a myriad applications, including the delivery
of therapeutics, the assembly of functional tissues and organoids, and design of protocells that display motility
and deliver drugs on cue; 2) Bring together a diverse group of speakers combining widely acknowledged
thought leaders early stage investigators that represent the gender diversity typical of researchers working in
the field; 3) Promote cross-disciplinary fertilization of new idea, in the format of a GRC, which is unique a
mixture of formal oral presentations, in-depth discussions and informal networking; 4) Create a sense of
community by promoting interaction between young and underrepresented scientists and early stage
investigators with prominent senior investigators in the field through the oral and poster sessions, and through
informal interactions such as social activities during the afternoon and evening; 5) Nurture the future
researchers of the field by offering a Gordon Research Seminar (GRS), which will precede the GRC and will
offer students and postdocs with comparable levels of education and experience the opportunity to gather,
present and discuss their research findings; 6) Idenitify the unique challenges of women in science in general
and in this field in specific with a Power Hour – a unique discussion venue found at GRCs - devoted to
discussing strategies for the advancement of women in bioinspired materials science.

Public health relevance
Project Narrative The 2022 Gordon Research Conference on Bioinspired Materials will be held June 5-10, 2022 in Les Diablerets, Switzerland. The conference will present current, cutting edge advances in the area of biomaterials science, with a significant emphasis on unpublished data, with topics ranging from self-assembled, responsive materials that delivery therapeutics, organoid and tissue design, novel materials to elicit and manipulate the immune response, and new ways to make responsive membranes and synthetic cells, all intimate format that is a hallmark of Gordon Conferences. The meeting will include early career investigators (graduate students, postdoctorals and untenured academic researchers) and will have a diversity in gender reflecting the attendance of the conference and discipline of biomaterials science as a whole.